Cardiovascular Disease Epidemiology & Prevention

Health workforce projections for the United States consistently indicate a shortage of well-trained
researchers in the fields of epidemiology and prevention. Importantly, the U.S. Bureau of Labor Statistics
reports that the employment of epidemiologists is projected to grow 26 percent from 2021 to 2031, much
faster than the average for all occupations. Meeting this surge in demand will require sustained support for
training programs across the U.S. This five-year proposal is for renewal of a longstanding training grant in
the epidemiology and prevention of cardiovascular disease administered by the Division of Epidemiology &
Community Health, School of Public Health, University of Minnesota. The program is highly successful,
having graduated 75 postdoctoral and predoctoral fellows since 1977. Among graduates in the past 15
years, 93% are currently in research positions, and 67% have obtained research funding, mostly from NIH.
The training program’s excellent facilities, large and diverse faculty, and broad research opportunities offer
an outstanding training environment. Our training program has continued to evolve and improve, to offer a
cutting-edge training experience in cardiovascular disease epidemiology and prevention.
In the most recent period (2019-2024), the program was awarded four predoctoral and three
postdoctoral fellowship positions. Positions have been filled throughout and we continue to have
outstanding applicants. Trainees from underrepresented groups comprised 43% of predocs and 29% of
postdocs appointed in the last five years. A total of 14 different faculty have served as a formal mentor for at
least one trainee during this same time period, demonstrating the breadth of expertise available to the
trainees and the extent of involvement of participating faculty in the delivery of training. Fellows have been
highly productive, generating impactful publications and presenting at national and international meetings.
Our proposal for renewal (2024-2029) is to maintain seven fellowship positions per year – three postdoctoral
and four predoctoral.
The University of Minnesota T32 fellowship program offers outstanding training opportunities in direct
research experience combined with a strong curriculum of formal coursework, seminars and expert
mentorship. The participation of disadvantaged trainees is a high priority for the fellowship. The
uniqueness of the training is the commitment of its faculty and the breadth of existing research, from the
laboratory to the community. The continued need for qualified cardiovascular epidemiologists and the
program’s documented success justify its renewal.

Public health relevance
Project Narrative This University of Minnesota program will provide training in cardiovascular disease epidemiology and prevention to 3 postdoctoral and 4 predoctoral (PhD) students. Trainees will learn how to formulate and conduct research to enhance understanding of the causes of cardiovascular disease and how to prevent them.